2010 In Vivo Magnetic Resonance Gordon Research Conference

DESCRIPTION (provided by applicant): This is an application requesting support for the 6th Gordon Research Conference (GRC) on: In Vivo Magnetic Resonance (MR). This meeting will cover an array of topics spanning the use of MR imaging and spectroscopy in cells, animals, and humans;addressing both basic science and clinical research issues. Particular emphases will be placed on emerging technological, biological, and health related matters that will significantly impact the growth of this remarkable imaging field. The 6th Conference will be held July 25 - 30, 2010, at Proctor Academy, Andover, NH. The Chair of the 6th Conference is Risto A Kauppinen, MD PhD, Director of the Biomedical NMR Research Center and Research Professor of Radiology, Dartmouth College, Hanover, NH;the vice-Chair is Craig Stanisz, PhD, Associate Professor, Department of Medical Biophysics, University of Toronto, Toronto, Ontario, Canada. The 5th In Vivo MR GRC was held in 2008 in the same location. The previous Conference was extremely successful. Significant advances in instrumentation, imaging speed, and in a wide array of advancements in coil and gradient technologies continue to create a rich environment for rapid growth of MR and its in vivo applications. It is both timely and necessary to gather together the leading individuals and future investigators to address, in depth, as is done at no other scientific venue, the next ventures of this important imaging science field. The In Vivo MR GRC will include scientific sessions, each with two to four speakers and a discussion leader. There will also be four poster sessions (from experience gathered in previous GRCs most participants will present a poster) and discussions designed to facilitate close interaction between the participants. By design, GRC meetings are small by conventional standards (approximately 140-150 participants) but participants will be invited/accepted in a manner to ensure attendance by a diverse group of junior and senior investigators representing academic and government institutions and individuals from corporate research programs. Students and postdoctoral fellows will be encouraged to attend. Junior investigators will be given opportunity for oral presentations. PUBLIC HEALTH RELEVANCE: Support is requested for the 6th Gordon Research Conference (GRC) on :In Vivo Magnetic Resonance: (July 25-30, 2010). Magnetic resonance (MR) techniques play a critical role in the delivery of high quality health care and MR is an essential player in the modern molecular medicine. The GRC meeting will emphasize emerging and cutting-edge technological, biological, and health related issues that will significantly impact the growth and application of this remarkable imaging field.

Public health relevance
NARRATIVE Support is requested for the 6th Gordon Research Conference (GRC) on “In Vivo Magnetic Resonance” (July 25-30, 2010). Magnetic resonance (MR) techniques play a critical role in the delivery of high quality health care and MR is an essential player in the modern molecular medicine. The GRC meeting will emphasize emerging and cutting-edge technological, biological, and health related issues that will significantly impact the growth and application of this remarkable imaging field.